Scalable Engineered Membranes for the Production of Low-cost Filter Devices for Single Cell Genomics

Single cell genomics has emerged as a potent tool for studying makeup, differentiation states and lineages of heterogeneous populations of cells. However, the widespread use of this technology is still limited by assay costs and access to specialized equipment. We propose to leverage a scalable solution for manufacturing free-standing photoresist membranes to generate filter devices capable of performing single cell genomic assays. This novel form factor will significantly decrease costs while simplifying cell loading procedures and improving cell loading efficiencies. Furthermore, these devices will not require extraneous specialized equipment and will therefore be able to be used in any lab. This technology will further accelerate the uptake of single cell genomic tools.

Public health relevance
Project Narrative The proposed work will demonstrate devices capable of delivering single cell genomics assays at a fraction of current costs. The cost reduction will accelerate the use of these technologies in a wide range of fields including immunology, neurobiology, cancer and stem cell biology where they are leading to breakthrough understandings in the causes of disease and the predictive efficacy of cancer therapies. In the future, single cell genomics will be extensively used to guide clinical care: by informing whether treatment is necessary, monitoring treatment and active disease, and detecting residual disease.